Interdisciplinary Training in the Chemical Senses

Project Summary/Abstract
The Monell Chemical Senses Center Postdoctoral Training Program, supported in part by Monell’s T32
Institutional National Research Service Award (NRSA), provides an opportunity for postdoctoral fellows to
obtain training at a center for research into the chemical senses—taste, smell and chemical irritation. The
eighteen faculty members participating in the training program have diverse scientific backgrounds and
conduct collaborative research using methods spanning many disciplines such as electrophysiology, molecular
biology, genetics, analytical chemistry, and psychophysics (applied to both humans and animals). Many Monell
trainees extend their expertise obtained in other fields to the chemical senses; the Center provides a
framework for them to apply skills learned elsewhere to chemosensory research. In addition to specialized
hands-on research training provided by faculty mentors, fellows attend instructional courses, workshops, and
Postdoctoral Journal Club meetings; they have opportunities for small-group review of data, one-on-one
assistance with clear scientific communication, and instruction on academic ethics tailored to their stage of
professional development. For each fellow, a mentoring committee composed of three faculty helps formulate
an Individual Development Plan for that fellow’s career path, tracks the fellow’s progress, helps set practical
scientific goals, suggests skill development opportunities, and provides written feedback every six months. In
response to the current pandemic, training plans have been modified to include remote-access Journal Club
meetings, seminars including an Interinstitutional Chemosensory Series, advanced training in workplace safety
including decontamination procedures, and transitioning where possible to online data collection. The training
program emphasizes teaching the skills to prepare results for publication and to write successful research
grants in an environment where faculty share common interests and trainees have access to specialized
infrastructure to study the chemical senses. During the previous funding period, Monell’s Institutional NRSA is
supporting or has supported 12 postdoctoral fellows: 4 are in training and 8 now have obtained individual
funding or have positions in academic institutions or elsewhere in the biomedical research workforce. All the
trainees have published papers in field-appropriate peer-reviewed journals or preprint archives, attended
national and/or international conferences, sought specialized training in courses and workshops, and become
familiar with standards for the responsible conduct of research (including rigor and reproducibility). Several
trainees have won awards for excellence in research; others have won competitive research grants, including
three F32 Individual NRSAs and one similar governmental award. The long-term goal of Monell’s Postdoctoral
Training Program is to train independent scientists in chemosensory biology, part of NIH’s mission to improve
the nation’s health.

Public health relevance
Project Narrative The Monell Chemical Senses Center is a multidisciplinary research institute devoted to improving health and well-being by advancing the scientific understanding of taste, smell, and related senses. Monell’s Postdoctoral Training Program provides interdisciplinary training for postdocs coming from a range of scientific disciplines, and we have trained 12 scientists under our T32 Institutional NRSA during the preceding funding period (4 of whom are still in training and 8 of whom have obtained individual postdoctoral funding or finished their training and taken on positions in the biomedical research workforce). We provide the tools for young scientists to gain independence—a high-yield scientific environment, committed faculty, and coursework in a range of biomedical research areas, including the responsible conduct of research—and we have adapted training to conduct science safely during the current pandemic.